3D printing of Tungsten Radial Collimator

3D printing of Tungsten Radial Collimator PolarOnyx Inc. proposes for the first time, based on our patented technology, an innovative approach to make tapered Tungsten radial collimator (W-Collimator) using fs fiber laser additive manufacturing, to provide high quality image for nuclear medicine. This provides unprecedented advantages over traditional methods in terms of sensitivity, cost, and effectiveness of prevention. The fs fiber laser delivers high peak intensity and power to melt the Tungsten powder and form the shape and strength required to diffract radiation. This technology combining with material processing capability provides a powerful tool for precise and timely manufacturing of Tungsten collimator with any complexity. In the Phase I, a proof of concept experiment to make Tungsten collimators with different shapes will be demonstrated and test on radiation imaging. In Phase II, we will further develop into a product exceeding the current sensitivity of SPECT/CBCT at least 1000x. APPLYING FOR NATIONAL INSTITUTE OF BIOMEDICAL IMAGING AND BIOENGINEERING (NIBIB) N. Nuclear Medicine

Public health relevance
3D printing of Tungsten Radial Collimator The proposed tapered Tungsten radial collimator, made with the proprietary 3D printing technology, is a breakthrough for SPECT/CBCT to improve the reliability of the image and to enhance the quality and lifespan of patients.